GROWTH HORMONE IN ADULTS WITH ACQUIRED GROWTH HORMONE DEFICIENCY

To determine whether administration of human growth hormone alters body composition, bone turnover, and carbohydrate metabolism in adults with growth hormone deficiency.